Light-Induced Atroposelective N-Heterocyclization via Chiral Perovskite Nanocrystals

Project Summary and Abstract
Novel method for constructing axially chiral N-heterocyclic molecules can have a
significant impact on the manufacture of pharmaceutical-active compounds and other
useful organic complexes. Our research program will develop a visible light induced
catalytic reaction approach that leads to the direct formation of chiral N-heterocycles that
were otherwise challenging to produce. The approach uses chiral semiconductor
perovskite materials as the catalyst which are directly derived from well-explored solar
cell materials that are bench-top achievable and economical to produce. In the proposed
strategy, organic substrates approach perovskite’s chiral surface for charge transfer,
leading to the key step for discriminate chiral configuration and thereby resulting in a
direct light-induced asymmetric ring-closure reaction. The unprecedented reaction
strategy described here is among the first of its kind, has the potential to introduce a wide
range of new asymmetric reactions for important axially chiral bio-relevant compounds,
and may be considered reliable linchpin reactions suitable for pharmaceutical synthesis.

Public health relevance
Project Narrative Chiral N-heterocycles are imperative scaffolds found in pharmaceuticals and biological processes. Our research program focuses on the development of novel methods for the economical and selective synthesis of such axially chiral N-heterocyclic compounds using small amounts of deliberately designed catalyst. Therefore, it is expected that the proposed research will have a significant impact on synthetic methodology and human healthcare.